Administrative Core

Administrative Core Summary/Abstract The Administrative Core is responsible for oversight and coordination of activities in the National Center for In Vivo Metabolism. There are three aims: 1. Administer the BTRC. This component will administer and coordinate general activities of the BTRC. The financial administration, interactions with the Advanced Imaging Research Center (AIRC), communication with Collaborative Projects, communication with Service Projects, and interaction with NIBIB will all be supported through the Administrative Core. One web programmer will be supported in the Administrative Core and responsible for development, implementation, and support of the BTRC web page. 2. Manage the Internal Advisory Committee (IAC). This Committee is composed of the leaders of the TR&D projects (Drs. Malloy, Sherry, Burgess, Kovacs and Wang) plus local experts with administrative support. The IAC has multiple responsibilities. It will receive and evaluate applications for consideration as a CP or a SP, monitor instrument usage and assure appropriate chargebacks, systemically review progress in each one of the CPs on a rotating basis with a report on the assistance received from each TR&D, and oversee distribution of 13C and 15N tracers as they are developed. The IAC will advise Dr. Malloy and the leaders of each TR&D project. 3. Manage the annual meeting of the External Advisory Committee (EAC). The EAC, described in more detail in the Administration section, will be composed of experts outside UT Southwestern. Each investigator in the TR&Ds brings a common interest in metabolism and NMR spectroscopy but also contributes highly distinctive strengths. The team is well-suited to serve the metabolic research community and the BTRC. We have experience working together for many years and opinions can be shared candidly. We are confident that that a well-integrated and responsive administrative structure can be provided to the Collaborators and Service investigators.